Advancing the Genomics Knowledge Base for Oral Diseases

Abstract
Oral diseases, mainly dental caries and periodontitis, affect approximately 3.5 billion people, and confer a
major global burden of disease. To make headway in better diagnosing, predicting, and managing dental
caries and periodontitis, efforts are needed to comprehensively characterize their genomic basis. Prior
genetics research has shown that both dental caries and periodontitis are heritable and has identified several
associations with specific genetic loci. Despite these efforts, there remain important gaps which need to be
addressed, such as the independent replication of previous genetic associations and the identification of novel
genetic associations and interactions that constitute the missing heritably. Likewise, efforts are needed to
leverage these genomic discoveries for clinical utility, for example, through the development of polygenic risk
scores and characterization of gene-by-environment interactions with potentially modifiable interacting factors.
Toward these ends, we propose to form a research consortium of more than 800,000 research participants
across at least 27 studies. We will perform the largest genome-wide association scans of dental caries and
periodontitis, develop polygenic risk scores, and identify gene-by-environment interaction effects. This project
will lead to better understanding of the genetic architecture of dental caries and periodontitis and their
potentially shared genetics with other human traits, produce new tools for DNA-based prediction, and identify
potentially actionable modifiable factors for precision dentistry. These new tools and knowledge will ultimately
lead to the development of preventive strategies with clinical utility for reducing disease burden and lessening
oral health disparities.

Public health relevance
Project Narrative This project seeks to perform the largest genome-wide association scans of dental caries and periodontitis, develop polygenic risk scores, and identify gene-by-environment interactions in a research consortium of over 800,000 adult participants of at least 27 studies. Knowledge gained may ultimately be useful for informing aspects of underlying biology, DNA-based risk assessment, and designing interventions to improve oral health.